CLINICAL EXPERIENCE AND USE OF VAGABATRIN (SABRIL) IN INFANTILE SPASMS

This is a multicenter, randomized, open-label, dose ranging, short-term study in which at least 44 chldren will have the opportunity to be treated with vagabatrin if they are 1) less than two years old: and 2) have had infantile spasms of three months or less in duration: and 3)have not been treated with standard therapies for infantile spasms (corticosteroids, ACTH, valproic acid, or clonazepam).